SERVICES FOR THE CHARACTERIZATION OF ABSORPTION, DISTRIBUTION, METABOLISM, EXCRETION, AND TOXICITY (ADMET) PROPERTIES OF SMALL-MOLECULE DRUG CANDIDATES USING STANDARDIZED IN VITRO METHODS IN SUPPORT O

The purpose of this contract is to determine in vitro ADMET (absorption, distribution, metabolism, excretion, toxicity) in two novel compounds using molecular methods. These experiments will help determine the drug-like properties of these novel compounds and their suitability for further development.